Wireless withdrawal detection and monitoring system for neonatal abstinence syndrome.

PROJECT SUMMARY
Neonatal abstinence syndrome (NAS) is an opioid withdrawal syndrome that develops shortly after birth to in
utero-exposed neonates. Newborns with NAS typically receive care in the Neonatal Intensive Care Unit
(NICU), where the daily cost of care is high, costing $1.5 billion per the 22,000 infants born with NAS each
year. [1] Although there are medication-based interventions for the treatment of NAS, which are used in up to
80% of opioid-exposed infants, these treatments carry their own risks of toxicity and drug interactions. [2]
Despite the steep medical costs and the risks of treatment, current tools to assess the severity of NAS are
subjective and suffer from examiner bias. [3] There is an urgent need for innovative new methods to reliably
diagnose NAS and thoroughly assess the efficacy of responses to treatment.
Rekovar has worked diligently to develop Neomonki (Neonatal Monitoring Kit), a simple economical solution to
objectively assess and treat NAS. Neomonki is an affordable, wearable monitoring device that reports
measures of behavioral and physiological symptoms correlating to NAS that may otherwise go unnoticed to
healthcare professionals. Neomonki consists of wireless wearable wristbands fitted with biosensor technology,
a tablet fitted with Rekovar’s healthcare portal enhanced with robust encryption/data collection capabilities, a
charging dock station which powers the tablet and allows easy access to recharge the wristbands, a camera
attached to the dock station to analyze imaging properties, and a portable cart which holds the dock station
and allows for easy repositioning of Neomonki. Neomonki will revolutionize neonatal healthcare with a cutting-
edge AI clinical algorithm that analyzes biosensor and imaging data to deliver predictive NAS analytics and
enhance diagnostic decision-making. Rekovar has successfully pursued several objectives to enhance the
performance of Neomonki, including size reduction and improved functionality and safety features. Rekovar
has also made strides in improving Neomonki’s software graphical user interface, ensuring that it is user-
friendly and functional. However, the success of the device is contingent upon the development of the AI
algorithm for assessing patient symptoms and prescribing appropriate treatments.
This proposal revolves around the collection of data in clinical trials to develop, optimize, and refine an
algorithm for assessing NAS symptoms in neonatal patients with the Neomonki. This will be done in two
phases: i) the collection of data in clinical trials and development/validation of the algorithm, and ii) submitting a
central IRB submission to deploy Neomonki in clinical trials collecting efficacy and safety data for premarket de
novo approval. These clinical trials will compare the performance of Neomonki against the currents standards
of care used by participating hospitals. A key milestone of this stage of the project is to assess whether the
optimized automated digital scoring and suggested treatment algorithm can reduce infant suffering, shorten
hospital stays, and decrease daily costs. Achieving this milestone will allow Neomonki to be used commercially
to automate digital assessments and treat patients.

Public health relevance
PROJECT NARRATIVE Rekovar is developing a low-cost wearable monitoring system that integrates wirelessly with a mobile device to allow real- time monitoring of the baby’s physical and physiological state and its ability to sleep, eat, and be nurtured while undergoing neonatal abstinence syndrome (NAS). This device has significant impact in helping reduce both hospital stay and costs as neonates receiving pharmacological treatment are usually in the NICU away from family and non- pharmacological care. Our interest lies with respect to proper neonatal care, where separate procedures occur for essential neonatal needs and needs for neonates undergoing withdrawal, and by using this monitoring device to assess addicted neonates undergoing withdrawal, caregivers are provided the better ability of treating the right neonatal needs with the appropriate procedure in hospitals.